ROLE OF NADPH-DEPENDENT REDUCTASES IN OCULAR COMPLICATION

In diabetes, the incidence and progression of complications associated with hyperglycemia have been linked to the production of sugar alcohols (polyols). The relationship between aldose reductase, other closely related NADPH-dependent reductases, and polyol production is being investigated to define the biochemical mechanism(s) that initiate the onset of these complications and to develop specific pharmacological methods of intervention.